NKA/CD36 signaling in adipocytes promotes oxidative stress and drives chronic inflammation in atherosclerosis

Atherosclerosis (AS) is a chronic inflammatory disease of medium and large arteries and remains the leading
cause of death worldwide from its sequelae of heart attack, stroke and limb loss. During AS progression
chronic activation of immune cells in the vessel wall, especially macrophages, leads to formation of lipid-loaded
foam cells which become the major component of atherosclerotic plaque. The goal is to discover molecular
mechanisms through which dyslipidemia and oxidative stress, which are major risk factors for AS, are linked to
chronic macrophage activation via dysregulated function of fat cells (adipocytes). The proposal will explore
how adipocyte-derived exosomes (Ad-Exo) carrying specific pro-atherogenic cargo such as miRNAs, are
generated under oxidative stress, and how they activate macrophages. Focus is CD36, type II scavenger
receptor highly expressed in adipocytes and macrophages that acts as a receptor for the atherogenic ligand
oxidized LDL (oxLDL). The oxLDL/CD36 signaling axis creates an inflammatory paracrine loop between
macrophages and adipocytes and facilitates oxidative stress and pro-inflammatory cytokine secretion through
Src family kinase (SFK) activation. Na/K-ATPase (NKA) α1 subunit serves both as a CD36 co- receptor and a
scaffold for the SFK, allowing conformational changes in the NKA to activate membrane bound SFK and
initiate signaling cascades, a mechanism distinct from its well-understood pumping function. Hypothesis of this
proposal is that activation of NKA/CD36 signaling in adipocytes produces oxidative stress that causes release
of adipokines and exosomes (Ad-Exo). These released factors initiate and augment AS by stimulating
macrophages. To test this hypothesis, 3 specific aims have been developed. The first will test the hypothesis
that adipocyte NKA/CD36 signaling complex promotes AS through production of cellular oxidative stress
leading to abnormal adipokines/exosome secretion. The approach will include use of the apoe null mouse
model and lentiviral vectors to deliver cell-specific NaKtide, a peptide reagent derived from the NKA α1 domain
that behaves as a specific inhibitor of the NKA/SFK pathway. Oxidant stress, AS plaque formation, and
adipocyte gene expression will be assessed using state-of-the-art techniques, such as next generation
RNASeq. The second aim will test whether Ad-Exo can modulate macrophage function in vitro and in vivo by
characterizing the proteome, lipidome and miRNA profile of Ad-Exo released in response to oxidative stress
and tracking their delivery to monocytes and AS plaque. A newly developed mouse model, GFP-
CD63flox/Adipoq Cre mice will be used as an excellent Ad-Exo reporter animal model for these studies. The
third aim will determine if Ad-Exo regulate macrophage lipid metabolism and mitochondrial function using
sophisticated metabolic flux assays along with lipidomic and gene expression assays. Successful completion
of this project will define an important concept that adipocyte CD36/NKA and downstream Ad-Exo secretion is
a driving force for chronic macrophage activation in AS, thereby identifying novel therapeutic targets.

Public health relevance
Oxidative stress is often associated with inappropriate activation of immune cells, including macrophages, leading to atherosclerosis which is the underlying cause of heart attacks, strokes, and ischemic limb loss. This project seeks to identify and characterize mechanisms that link oxidative stress in fat cells (adipocytes) to chronic macrophage activation through activation of specific cellular receptors and release of bioactive materials. The novel molecular pathway identified in this proposal could lead to new strategies for therapeutic interventions.